Manipulating Neural Oscillations with Non-Invasive Sensory Stimulation for Alzheimer's Disease Intervention

Alzheimer's disease (AD) is an incurable brain disorder, with a staggering human and financial cost in a rising
aging population. The complexity of its pathophysiology has proven to be a daunting challenge in the
development of effective pharmacological interventions. We have recently shown that noninvasive Gamma
ENtrainment Using Sensory stimuli (GENUS) to induce neural oscillations in the gamma frequency range (30-
90 Hz) could ameliorate pathology in various AD mouse models. Mice subjected to GENUS regime exhibited
positive effects on microglia, astrocytes, cerebral vasculature, as well as reduced accumulation of amyloid and
hyperphosphorylated tau in respective amyloid and tauopathy mouse models. However, the mechanisms by
which GENUS impacts cell-cell interactions, in particular, interactions between neurons and microglia, are not
clear. To this end, we will utilize a combination of AD mouse models and innovative iPSC 3D co-culture system
to assess the role of microglia in modifying the GENUS response, focusing on the contributions of microglial AD
risk genes, APOE and TREM2, in modulating the neuroimmune interactions in response to GENUS.

Public health relevance
The activity of cells and neural circuits are altered in Alzheimer's disease (AD), and may represent a point of therapeutic intervention to affect disease progression. We recently found that manipulating oscillations in the gamma range with noninvasive auditory and visual sensory stimuli promotes neuroimmune interactions and alleviates AD-associated pathology in multiple disease mouse models, but the mechanisms by which GENUS promotes neuroimmune interactions are not clear. We will investigate the effects and potential mechanisms by which GENUS impacts the cellular and molecular responses of neuroimmune interactions, particular those mediated by microglia, and how microglial AD risk genes, APOE4 and TREM2, modifies GENUS-mediated neuroimmune activity that could affect AD pathology and cognitive function.